Case-Control Study of Methamphetamine in Pulmonary Arterial Hypertension

The long-term objectives of this application are to establish the epidemiological association between
methamphetamine use and pulmonary arterial hypertension. Methamphetamine and other stimulant abuse
have been increasing across the United States and the world with several known complications. Pulmonary
arterial hypertension has been suspected to occur as a sequela, however this has never been studied in a
rigorous multicenter epidemiologic study. Preliminary findings have suggested that carboxylesterase 1 (CES1)
may be an important genetic modifier in the setting of methamphetamine use leading to pulmonary arterial
hypertension. The Specific Aims are 1) to determine whether methamphetamine use is associated with PAH in
a case-control study and whether this association is modified by genetic variants in (or activity of) CES1; 2) to
determine the risk factors for clinical worsening in patients with methamphetamine-associated pulmonary
arterial hypertension in comparison with idiopathic pulmonary arterial hypertension in a prospective cohort
study; and 3) to understand if reductions in CES1 activity result in human pulmonary endothelial cell damage in
methamphetamine-associated pulmonary arterial hypertension. Patient-oriented research studies will be
conducted in a multicenter study group to address these epidemiologic questions.

Public health relevance
Project Narrative Methamphetamine and other stimulant abuse have been increasing across the United States and the world with several known complications which can result. This grant will study the relationship between methamphetamine use and the presence of pulmonary arterial hypertension in a case-control epidemiologic study.